Fragile Families and Child Wellbeing - Young Adulthood

Project Summary/Abstract: FRAGILE FAMILIES AND CHILD WELLBEING – YOUNG ADULTHOOD
The Fragile Families and Child Wellbeing Study (FFCWS) is a birth cohort study following a stratified,
multistage, population-representative sample of children born in large US cities between 1998 and 2000. This
proposal requests funding to survey the children in young adulthood, around their 27th birthdays.
The study began with interviews conducted with mothers and fathers at birth. Fathers were interviewed again
when young adults were 1, 3, 5, and 9. Mothers were interviewed again when children were 1, 3, 5, and 9.
Primary caregivers were interviewed when the young adults were ages 15 and 22. Young adults were
assessed/interviewed at ages 3, 5, 9, 15, and 22. Saliva samples were collected from mothers at age 9 and
from children at ages 9, 15, and 22.
The original study design called for a large oversample of births to unmarried parents, and the sample is very
diverse (the mothers are 48% Black, 27% Hispanic, and 21% white), making the data a valuable resource for
studying racial and economic disparities in health and wellbeing. The age 22 interviews occurred in the context
of the COVID-19 pandemic and included detailed questions about education, employment, income, health,
housing, and family resource-sharing during the pandemic. To date, more than 8,700 researchers have used
the data, resulting in the publication of more than 1,110 journal articles, 44 books and book chapters, 150
dissertations, and 115 working papers.
Specific aims:
(1) Collect data on the health and wellbeing of FFCWS young adults at age 27, including data on: a)
socioeconomic status (education, employment, and income), b) family formation (intimate relationships,
childbearing), c) health (self-reported physical and mental health), d) program participation (including
health insurance, social services, cash and near-cash assistance, housing assistance) and e) systems
involvement (experiences with the police and criminal justice system).
(2) Collect innovative data on the social, economic, and physical environments of FFCWS young adults at
age 27, including: a) family relationships and intergenerational support/obligations, and b) local area
contexts such as policy regimes, neighborhood environments, and labor market conditions.
(3) Obtain permission to access FFCWS young adults’ education, employment, health, and other
administrative records (if not obtained at age 22).
To accomplish these aims, we will contact approximately 3,600 young adults through a web-based survey
around their 27th birthdays. Young adults who do not initially complete the web-based survey will receive phone
or in-person follow-up and the interview will be administered by a trained interviewer.

Public health relevance
THE FRAGILE FAMILIES AND CHILD WELLBEING STUDY – YOUNG ADULTHOOD Project Narrative The Fragile Families and Child Wellbeing Study is the US’s longest-running contemporary national birth cohort study and, with age 27 data, will allow researchers to examine how experiences and exposures across childhood, adolescence, and early adulthood influence health and wellbeing in young adulthood. The sample is very diverse, allowing researchers to examine racial, ethnic, and socioeconomic disparities in health and wellbeing. Further, the multigenerational nature of the study will allow researchers to examine intergenerational mobility and persistence of a wide range of health and wellbeing outcomes.